Niche Partitioning of Commensal Clostridia in the Gut

PROJECT SUMMARY/ABSTRACT
Given the importance of the gut microbiota to human health and disease, there is great interest in defining how
the indigenous microbes in these communities assemble and function in health. Ecological succession of the
microbes that compose the gut microbiome begins at birth, with diversification of the community throughout
human life. A key role for the gut microbiota is to break down resources from our available diet, which provides
us with necessary nutrition to live. This also sustains other surrounding microbes, increasing microbiota
diversity and resilience to environmental perturbation. In conjunction with the rich nutrients provided by the gut
environment, the ability of a bacterium to diversify its nutrient acquisition repertoire can allow for related strains
to establish new niches and coexist in a community. As such, niche partitioning among individual species or
strains likely to contributes to maintenance of a diverse microbiota. Niche partitioning of select model
commensal microbes of the gut, such as Bacteroides species, has been demonstrated, providing critical
knowledge about the cooperative and competitive interactions that contribute to their assembly in the gut. Yet,
we still lack comprehensive information about the metabolic strategies for many prevalent species in the gut,
let alone how these species interact together to maintain a particular community structure. Understanding how
non-model microbes assemble in the gut is important, as successful implementation of many targeted bacterial
functions still rely on their surrounding community members. In this proposal, we aim to characterize the
metabolic role of commensal Clostridia, which represent prevalent members of the gut microbiota that are
under-characterized. We hypothesize that similar to what is known about more well-defined gut commensal
species, nutrient niche partitioning among Clostridial species is essential to sustaining their diversity in the gut.
We will use bioinformatic and in vitro methods to 1) characterize the fundamental (genonme-encoded) and
realized (expressed) metabolic strategies used by select Clostridial species and 2) identify how these
contribute to their assembly in the gut. Results from these data provide critical information about core
functions, strain heterogeneity, and microbial interactions that are relevant to understanding comprehensive
assembly of the human gut microbiota. These data provide a foundation for mechanistic studies surrounding
commensal Clostridia in the gut, such as developing rational bacterial consortia or dietary interventions based
on these fundamental characteristics. Overall, this proposal provides a path forward for our independent
research program focused on understanding the role of commensal Clostridia in health.

Public health relevance
PROJECT NARRATIVE The proposed work seeks to characterize the metabolic footprint of commensal Clostridia and investigate how this contributes to their microbial assembly in the gut. Completion of the proposed work provides fundamental knowledge about prevalent yet under-characterized human gut commensals and their role in human health and disease, all of which advance our ability to manipulate the gut microbiota for our benefit.